Functions of G-proteins in Endothelial Cells

Project Description The main focus of this application is on the functions of G-proteins in endothelial cells. G-protein Gα13 is critical for blood vessel formation. This proposal builds on our discovery of a novel mechanism by which Gα13 functions through SOS, a direct regulator of Ras and the new observation that endothelial cell-specific deletion of Gα13 impairs organ regeneration. The first aim is to dissect the biochemical mechanism by which Gα13 regulates SOS in vitro. The second aim is to determine how Gα13 and G-protein- coupled receptors regulate SOS in cells. The third aim is to investigate the impact of endothelial cell-specific deletion of SOS1 on organ regeneration.

Public health relevance
Public Health Relevance Statement This research is directly related to human health. Endothelial cells are essential for angiogenesis and vascular development. Therefore, a better understanding of the regulatory mechanisms of endothelial functions will advance our combat against many human diseases such as cardiovascular diseases and cancers.